Spinal cord structure-function relationships in degenerative cervical myelopathy

ABSTRACT: Degenerative cervical myelopathy (DCM) is the commonest cause of spinal cord dysfunction in
older adults and an important cause of disability and impaired quality of life. Conventional MRI, which is used for
surgical planning, does not distinguish irreversible spinal cord damage and is frequently inconsistent with clinical
examination. Routine clinical assessment for DCM relies on subjective symptom scores, and lacks objective
quantifiable measures of function. Neither of these current standards of practice overcome the disassociation
between radiology and clinical function in DCM, and neither are strong predictors of surgical outcome. To
overcome the lack of pathological specificity of diffusion tensor imaging (DTI), we developed filtered diffusion
weighted imaging (fDWI), which enhances detection of axonal injury. We developed metal-suppression multi-
spectral diffusion weighted imaging (MSI-DWI) to assess post-surgical spinal cord microstructure in the presence
of spinal instrumentation. To better identify the functional correlates of these novel imaging approaches, we
demonstrate techniques to assess subtle sensorimotor dysfunction in DCM. The long term goal of this project is
to incorporate advanced multi-parametric spinal cord MRI in the routine clinical assessment of DCM to improve
diagnosis and prognostication of surgical outcome. The overall objective of this project is to determine if
quantification of spinal cord microstructure and function can disambiguate clinico-radiologic data in DCM and
improve prognostication of outcome after surgery for DCM. The first aim will determine if multi-parametric MRI
measures of axonal injury (fDWI) and demyelination (magnetization transfer [MT] imaging) can outperform
conventional MRI for structure-function correlations. To achieve the second aim, we will use quantitative tests of
motor, sensory and balance function to objectively track functional recovery after surgery and determine if these
measures are superior to standard symptom scores. The third aim will use post-surgical MSI-DWI to detect
microstructural changes in the decompressed spinal cord that are associated with quantitative function after
surgery. Together, the successful completion of these aims will advance the clinical translational of
multiparametric spinal cord MRI for diagnosis, prognostication and monitoring of spinal cord integrity in DCM.

Public health relevance
PUBLIC HEALTH RELEVANCE: Degenerative cervical myelopathy (DCM) is a major cause of spinal cord dysfunction and disability in older adults. This project will use novel spinal cord imaging and functional assessments to improve prediction of outcomes after surgery for DCM. This will enhance our knowledge of recovery of function and reduction of disability in DCM.